Targeting innate immunity for induction of robust renal allograft tolerance

SUMMARY
Establishing a reliable method to achieve allograft tolerance remains an ultimate goal in organ transplantation.
We previously reported long-term immunosuppression (I.S.)-free renal allograft survival in humans after
induction of only transient hematopoietic chimerism through donor bone marrow transplantation. To expand the
application of our approach, it is now imperative to 1) improve the consistency and robustness of hematopoietic
chimerism and allograft tolerance; 2) refine the conditioning regimen by identifying novel agents that can induce
mixed chimerism without genotoxic adverse effects; and 3) expand the understanding of mechanisms whereby
I.S.-free renal allograft acceptance via induction of transient mixed chimerism is achieved.
There is ample evidence that proinflammatory responses during the peri-transplant period adversely affects long-
term outcome of the allograft and tolerance induction. Integrin CD11b/CD18 (CD11b) is highly expressed on the
surface of innate immune cells and modulates several key proinflammatory functions in innate immune cells.
Our previous studies showed that blocking CD11b with mAb107, a first-in-class pure antagonist of CD11b,
markedly limits reperfusion injury after prolonged warm ischemia of native kidney or kidney allografts in
nonhuman primates. These observations led to our preliminary studies for this application that revealed superior
long-term outcome of renal allografts as well as improved hematopoietic chimerism in recipients of mAb107.
Therefore, in Aim 1, we will test the hypothesis that blocking CD11b with mAb107 in our mixed chimerism
protocol will induce a more robust allograft tolerance.
To reduce comorbidity of our conditioning regimen for bone marrow transplantation, we recently showed that
selective Bcl-2 inhibition with Venetoclax significantly promotes hematopoietic chimerism and allograft tolerance
with minimal myelosuppressive complications. However, complete elimination of genotoxic treatments from the
conditioning regimen was not achieved with Bcl-2 inhibition and a minimal non-toxic dose of total body irradiation
(TBI) was still required. ImmTOR is synthetic biodegradable nanoparticles encapsulating rapamycin. It can be
rapidly endocytosed by dendritic cells and other myeloid cells and induces antigen-specific non-responsiveness
in NHPs and humans. We therefore hypothesize that potent immunomodulatory effects of ImmTOR may more
effectively protect allogeneic HSCs from alloimmune responses, allowing engraftment of HSCs without any
genotoxic treatments. Our preliminary studies with ImmTOR are encouraging with multilineage mixed chimerism
being induced without irradiation and chemotherapy.
Finally, we will elucidate the mechanistic pathways involved in successful I.S.-free renal allograft survival by
transient hematopoietic chimerism induced by mAb107 and ImmTOR, utilizing extensive in vitro and in vivo
experiments with novel immunological approaches. Our hypothesis is that the major tolerance mechanism will
be defined as regulatory but deletional mechanisms are also involved.

Public health relevance
NARRATIVE We have achieved in nonhuman primates and in initial clinical trials the induction of transient hematopoietic chimerism and long-term I.S.-free renal allograft survival, following combined MHC mismatched kidney and BM transplantation. The proposed research studies will evaluate novel conditioning modalities aimed at improving the consistency of tolerance induction as well as eliminating the genotoxic components from our current regimen, by using a unique mAb107 directed against the archetypal innate immune receptor CD11b, and ImmTOR, nanoparticles containing rapamycin, that potently modulate innate and adaptive immunity towards the allograft. Our preliminary studies indicate that these approaches will provide safer and more effective recipient conditioning, which will make this tolerance strategy available to many more transplant recipients. Our NHP model has been proven to provide strong correlations with subsequently observed outcomes in humans. Thus we anticipate that the results of these studies will be directly applicable to clinical trials.